AN INTEGRATED SYSTEM FOR IMAGE-GUIDED RADIOFREQUENCY ABLATION OF LIVER TUMORS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Project Summary Grant Number: RO1CA124377 Project Start: 14-Sept-2007 Project End 31-Jul-2012 The overall goal of this proposal is to develop and validate an integrated system based on open source software for improved visualization and probe placement during radiofrequency ablation (RFA) of liver tumors. While radiofrequency ablation is becoming an increasingly important treatment option for unresectable hepatocellular carcinoma (HCC) and liver metastases, the procedure has several technical limitations. These limitations are mostly related to the difficulty of precisely placing the RFA needle to ablate the entire tumor and achieve adequate margins. In particular, larger tumors require multiple overlapping needle placements, which can be difficult to achieve. The specific aims of the project are to: 1) Develop an open source software architecture for a liver RFA planning/treatment workstation that builds on existing open source projects at the two collaborating institutions 2) Develop and evaluate semi-automatic segmentation techniques for the liver, liver vasculature, and liver tumors. These techniques will be integrated with a graphical user interface and the segmentation results will be evaluated by comparison with expert radiologists. 3) Based on the segmented liver data set, develop a path planning module for evaluating alternative paths to the liver tumor and incorporating multiple overlapping placements as needed. 4) Integrate the two capabilities developed above along with electromagnetic tracking of the RFA probe to provide a complete software environment for liver tumor planning, visualization, and execution. This software environment will merge ongoing work at Georgetown and Brigham and Women's Hospital in developing open source software for image-guided procedures. 5) Validate the clinical feasibility of the system in a swine animal model. Agar nodules will be created in the swine liver and the ability of the system to segment and provide path planning for these nodules will be assessed. The accuracy of the system will also be evaluated. This research is important in advancing the technology for treatment of liver cancer that presently can not be treated well with current available therapies. This technology would also enable a modern, individualized therapy, which relies on integration of high power computers and innovations in medical science. It would have a contribution to public health by developing liver cancer treatments without the need for more invasive surgeries. Benefit to NCIGT and the Project The overall goal of this proposal is to develop and validate an integrated system based on open source software for improved visualization and probe placement during radiofrequency ablation (RFA) of liver tumors. This collaboration between Georgetown and the Computation and Prostate cores of NCIGT, allows us to add a Liver RFA module to Slicer IGT, and it allows the Georgetown group to leverage the functionality of the Slicer platform, as well as the clinical expertise in the Prostate group where Dr. Clare Tempany, Radiologist and core PI, provides feedback on its clinical utility.